Optimal RNA-based therapeutics for vocal fold injury and fibrosis

DESCRIPTION (provided by applicant): The universality of fibrosis as an underlying etiology for many voice disorders stems from the reparative response to injury. To date, treatments have been largely unsatisfactory. Acknowledging that healing is complex, we seek to expand our recent findings elucidating one regulatory mechanism underlying repair in the vocal folds. Specifically, we seek increased insight into the transforming growth factor (TGF)-β signaling cascade. Our preliminary data suggest that targeting this pathway, not TGF-β directly, but rather upstream, to be optimal. Smad3, an upstream cytoplasmic signaling protein provides an ideal target for the use of RNA- based therapeutics, specifically small interfering ribonucleic acid (siRNA). However, delivery of siRNA in vivo is complicated by the inherent proteolytic environment. We hypothesize that lipid nanoparticle delivery will address these issues, delivering optimal drug concentrations with reduced toxicity. This investigation is germane; cumulative estimates regarding the incidence of voice disorders across the lifespan are not known, but are hypothesized to be higher than the 3-9% of the population figure that is often cited. This innovative approach has potential to evolve to the clinic across multiple organ systems.

Public health relevance
PUBLIC HEALTH RELEVANCE: Vocal fold fibrosis is a source of common, debilitating voice disorders and treatments remain unsatisfactory. We seek to employ RNA-based therapeutics and furthermore optimize in vivo delivery of these compounds with the ultimate goal of facilitating a more regenerative model of healing in the vocal folds.